Machining and Prototyping Research Core (MAPRO)

Program Director/Principal Investigator (Last, First, Middle): Stergiou, Nick
Project Summary
In Phase 2, the Machining and Prototyping (MAPRO) Research Core was established to provide access to state-
of-the-art manufacturing equipment and highly skilled personnel for the design, fabrication, and maintenance of
cutting-edge research devices to support human movement-related research, being a distinctive and defining
activity for our MOVCENTR. In Phase 3, we plan to optimize our successful research core by improving efficiency
and project management and to establish a more collaborative, multidisciplinary environment to address intricate
issues related to human movement variability in cutting-edge facilities. This will be accomplished with the
following specific aims: 1) Maintain state-of-the-art resources for the design and fabrication of custom research
devices and instrumentation and provide technical support for the interdisciplinary studies conducted by
academic and industrial researchers. 2) Serve as a conventional and advanced training and mentoring center
for all MOVCENTR investigators, including undergraduate and graduate students as well as postdoctoral fellows,
in the development of cutting-edge manufacturing equipment, techniques and software that can be used to
create new and innovative research devices and clinically translatable products. 3) Provide expertise in the
development of new and innovative devices to treat and prevent movement related disorders and set-up strong
collaborations with researchers of the University of Nebraska at Omaha (UNO), the state of Nebraska, the Great
Plains IDEA-CTR network, and beyond. Our vision is to offer our MAPRO’s services to bring to life novel and
impactful ideas from researchers and physicians throughout the medical and health fields.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page 1 Continuation Format Page